Biomedical Computing Support for the Divison of Cancer Control and Population SciencesPeriod of Performance: 08/16/2014 - 08/15/2015

Biomedical Computing Support for the Division of Cancer Control and Population Sciences